TAP TAGGED INSULIN-SIGNALING PATHWAY IN HEK293T

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This project is almost entirely based upon the work of Josh McElwee. The Insulin/IGF-1-like (IIS) pathway has been a pathway of great interest in the field of aging since modulation of components of the pathway extend lifespan significantly in taxonomically diverse model organisms. This study seeks to identify the key interacting partners of factors in this pathway in human cells as well as changes in interacting partners under serum-starved conditions. We hope to uncover new candidates for future study of this pathway in regards to aging. The response of this pathway to serum-starved conditions may provide insight into the relationship of this pathway and caloric restriction, another conserved mediator of longevity.